National Health and Nutrition Examination Survey, Cardiovascular Disease and Respiratory Health Component/Study (NHANES)

To provide support to the National Center for Health Statistics (NCHS), for the Cardiovascular Disease and Respiratory Health Component/Study in the 2025-2026 National Health and Nutrition Examination Survey (NHANES).